Pre-vascularization of an Integrated 3D Human Osteo-Mucosal Model

Summary:
This proposal builds upon our recent completion of an NIH grant titled “Development of an Integrated 3D Human
Osteo-Mucosal Model,” for which our team stands as the sole entity to have successfully developed this model.
During that project, we engineered an osteo-mucosal construct, overcoming various challenges, particularly in
establishing robust adhesion between the soft and hard tissue sections. Now, with this proposal, we aim to bridge
the gap between our previous grant and future directions. More specifically, given that the osteo-mucosal
construct is inherently critical-sized, the challenge of vascularization hinders the advancement of this research
for pre-clinical examinations. It is evident that non-vascularized constructs are prone to failure when implanted
into critical-sized defects. Therefore, this proposal is dedicated to addressing this challenge by focusing on the
pre-vascularization of the previously developed osteo-mucosal construct and evaluating its effectiveness in vivo.
To achieve this goal, we will implement key angiogenesis strategies that synergistically activate pre-
vascularization. More specifically, we will harness the synergistic effects of intracellular and extracellular
mechanisms to further promote pre-vascularization. Specifically, we will utilize FG-4592 (Roxadustat), a hypoxia-
inducible factor prolyl hydroxylase inhibitor (HIF-PHI), known for its intracellular mechanism. FG-4592 stabilizes
HIF-1α by inhibiting HIF-prolyl hydroxylases, thereby preventing its protease degradation within the cells. This
process facilitates the expression of relevant genes and promotes angiogenesis. Notably, FG-4592 is currently
undergoing global Phase III clinical trials for the treatment of anemia. In addition to FG-4592, our model
incorporates an aptamer targeting an extracellular mechanism. This aptamer binds effectively to both VEGF
receptors 1 and 2 (VEGFR-1 and -2), with a notably stronger affinity for the latter, thereby facilitating the
promotion of angiogenesis.
The osteo-mucosal construct will be created using 3D-printed scaffolds loaded with these pro-angiogenic factors
and seeded with HUVECs and supporting cells. The research involves comprehensive in vitro testing to promote
blood vessel formation, followed by in vivo studies using a rat alveolar bone model with overlaying gingiva to
evaluate the construct's integration with host tissue, and formation of well-defined and interconnected vascular
networks. The success of this approach will be measured by the density and functionality of the blood vessels
with capillary density of 50-100 vessels/mm² in bone tissue and 30-60 vessels/mm² in mucosal tissue.
The osteo-mucosal complex presents one of the most challenging multi-tissue defects. It represents a key
example of critical-sized defects, and its successful regeneration can establish a robust approach for treating
other critical-sized defects involving both hard and soft tissues. Furthermore, a laboratory-grown osteo-mucosal
construct derived from a patient's own cells proves immensely beneficial for oral surgeries. Moreover, it offers
an alternative to animal models for studying biomaterial-oral tissue interactions and for screening oral diseases.

Public health relevance
NARRATIVE We have recently developed a laboratory-grown construct consisting of bone and oral mucosa, wherein the hard and soft tissues are strongly adhered. While this osteo-mucosal construct holds promise for use in oral surgeries, its lack of vascularization presents a significant challenge due to its inherent large size, inevitably leading to failure without proper vascular support. To address this challenge, this proposal aims to pre- vascularize the previously developed osteo-mucosal construct and subsequently test it in a rat alveolar bone model with overlaying gingiva.